Development of an ophthalmic diagnostic probe for cerebral amyloid angiopathy in patients

Project Summary
Cerebral amyloid angiopathy (CAA) is a common neuropathological finding among older adults and is
characterized by amyloid beta (Aβ) deposits in blood vessel walls of the brain. CAA is a major cause of
spontaneous intracerebral hemorrhage and is an important contributor to age related cognitive decline.
Diagnosis is often missed by physicians as the presenting symptoms are similar to a stroke and can be further
complicated as CAA is found in over 80% of Alzheimer's disease patients. Standard diagnosis of probable CAA
involves expensive imaging techniques and an invasive brain biopsy. The only definitive way to diagnose CAA
is through post-mortem analysis. An antemortem diagnostic is needed that can reliably identify CAA at the early,
asymptomatic stages, enabling a correct diagnosis to avoid medications contraindicated in the disease, which
can increase the individual's stroke risk. Furthermore, a useful and affordable outcome marker is needed for
clinical trials focused on therapies for CAA that could stop or reverse the progression of the disease. Amydis
aims to address these unmet needs by identifying A in the eye, as a window to the brain, for early detection of
CAA. Amydis is meeting this need with the development of a novel retinal diagnostic probe. Our novel retinal
diagnostic probe, AMDX-2011P, has fluorescent properties amenable for use with standard retinal imaging
equipment found in the ophthalmologists' office and fluoresces at a wavelength suitable for use with conventional
instruments, it penetrates the retina when administered systemically at significant concentrations, is non-toxic in
preclinical animal models, and has crystalline properties that allow for consistent large-scale manufacturing. In
this proposal, Amydis will manufacture AMDX-2011P under GMP guidelines, formulate AMDX-2011P for i.v.
delivery, test stability, and then undertake a phase 1 clinical trial with single ascending doses in healthy subjects
(N=24) and then test the optimal dose in a small cohort of CAA patients (N=5). Completion of these aims will
advance the development of our in vivo ocular diagnostic test, getting us one step closer to our mission of
providing an antemortem, simple, and affordable CAA diagnostic.

Public health relevance
Project Narrative Cerebral Amyloid Angiopathy (CAA) is an age-associated disease where amyloid builds up on the walls of the arteries in the brain, increasing the risk for stroke. Retinal abnormalities have been reported in patients that mirror the known histopathology of CAA in cerebral vessels. The proposed research aims to advance an ocular antemortem diagnostic probe for amyloid detection and CAA diagnosis.